Adapting and Piloting an Evidence-based Intervention to Improve Hypertension Care among Tanzanians Living with HIV

Abstract
In sub-Saharan Africa (SSA), people living with HIV (PLWH) face a new epidemic of uncontrolled
hypertension, the leading risk factor for death worldwide. Current care models in SSA are inadequate to
address the growing burden of hypertension in PLWH, yet few interventions targeting this population exist. We
previously piloted Community Health Worker (CHW)-delivered Hypertension Management Pilot (CHAMP), a
clinic-based hypertension educational intervention delivered by a CHW situated within a Tanzanian HIV clinic,
and found it to be highly feasible and acceptable. However, the efficacy and sustainability of CHAMP remains
unproven. In contrast, Control of Blood Pressure and Risk Attenuation (COBRA), a multi-component
intervention consisting of community-based CHW-delivered education and blood pressure monitoring and
protocolized referrals to physicians, demonstrated efficacy in improving hypertension control and reducing all-
cause mortality in a cluster-randomized trial across 3 countries in Asia. Evidence-based interventions like
COBRA hold considerable promise in achieving hypertension control among PLWH in SSA, but have not been
studied in this population.
In this 2-year study, we will integrate an evidence-based, multi-component, CHW-delivered hypertension
intervention (COBRA) with our early experience deriving CHAMP to improve hypertension care and reduce
blood pressure among PLWH in Tanzania. Using implementation science methods, we will adapt COBRA for
delivery within the Tanzanian HIV clinic, examine implementation outcomes, and estimate effect size in
preparation for a subsequent large-scale, hybrid effectiveness-implementation trial across Tanzania. In Aim 1,
we will assemble a Design Consultation Team of key stakeholders to assist in intervention adaption.
Adaptation and integration of COBRA and CHAMP will occur iteratively over 8 months, guided by the ADAPT-
ITT model, and informed by our previously collected qualitative data describing barriers and facilitators to
hypertension care for PLWH. In Aim 2, we will pilot the adapted intervention with a single arm pre-post
feasibility trial in two HIV clinics and assess implementation (reach, adoptability, implementation, maintenance)
and preliminary effectiveness outcomes (hypertension control, systolic and diastolic blood pressure,
antihypertensive adherence, cardiovascular disease risk score, and hypertension knowledge). Our research
team, comprised of experts in hypertension, HIV, and implementation science and our robust relationships with
community agencies and health systems make us well-suited to conduct this work.
The proposed program will lay the groundwork for an R01 application to evaluate implementation,
effectiveness, and scalability of the adapted intervention in a fully powered trial across Tanzania and help stem
the rising tide of cardiovascular comorbidities among PLWH in SSA.

Public health relevance
Project Narrative Uncontrolled hypertension, the leading risk factor for death, is exceedingly common among people living with HIV (PLWH) in sub-Saharan Africa (SSA). Despite the pressing need to develop hypertension care models for PLWH in SSA, few effective interventions targeting this population exist. Using an implementation science approach, this project will adapt an evidence-based hypertension intervention, proven effective in other settings, for integration within HIV clinics to improve hypertension control among Tanzanians living with HIV.